Lay Coach-led Early Palliative Care for Underserved Advanced Cancer Caregivers

Each year in the United States, more than 600,000 individuals die from cancer, with most receiving intensive support in their final months from family and friend caregivers (FCGs). Historically under-resourced FCGs are especially likely to experience high-intensity caregiving with fewer supports and resources. This context has been linked to worse outcomes for both patients and caregivers at the end of life (EOL), including elevated distress, poor quality of life (QOL), and increased healthcare utilization. After the patient’s death, bereaved caregivers from these populations are also more vulnerable to prolonged psychological and emotional challenges. Despite their critical role, few interventions have been tested to determine whether early palliative care (PC) can improve long-term outcomes for historically under-resourced FCGs and their care recipients. This project seeks to address that gap by extending follow-up and outcome evaluation in an ongoing randomized hybrid type I effectiveness-implementation trial of ENABLE Cornerstone, a lay navigator-led early PC intervention tailored to the needs of historically under-resourced FCGs of patients with newly diagnosed advanced cancer. Rooted in Pearlin’s Stress-Health Process Model, the intervention includes six structured sessions plus monthly follow-up from diagnosis through early bereavement. Lay navigators provide support in stress management, coping, help-seeking, caregiving skills, and decision-making. The proposed study will leverage an ongoing trial and focus on longitudinal caregiver and patient outcomes through the EOL period and 24 weeks post-patient death. Specifically, Aim 1 will test whether Cornerstone improves caregiver distress, QOL, and burden in the 24 weeks prior to death. Aim 2 evaluates effects on patient distress, QOL, quality of death and dying, and EOL healthcare utilization. Aim 3 assesses bereavement outcomes for caregivers, including distress, resilience, burden, grief, and QOL up to 24 weeks post-loss. This work is directly responsive to calls for research on interventions to support adult cancer caregivers. It also addresses critical gaps identified by the National Cancer Institute, the National Institute of Nursing Research, and the National Academies, including the lack of attention to under-resourced populations and insufficient evidence of long-term impacts. If successful, this highly scalable intervention could meaningfully improve caregiver and patient outcomes during the most critical stages of the cancer journey, while informing future dissemination and policy efforts aimed at optimizing EOL care and bereavement.

Public health relevance
The burden placed on family caregivers and the toll on their mental and physical health have never been greater and will continue to rise; by 2026 the number of individuals with cancer is expected to swell to over 20 million and in 2019, the number in the their last year of life was over 600,000. Healthcare clinicians should be concerned with the health of family caregivers for their own sake (e.g. preventing future family caregiver morbidity), but also because these caregivers deliver 80% of the home care to community-dwelling patients with advanced illness. Replacing these services with paid professional help would be economically unfeasible as caregiving services have been valued at $450 billion; thus it is imperative that interventions be developed that keep caregivers healthy and functioning, not only for their own sake, but also so they can provide the best care possible to patients with cancer.